NIAID Transition Program in Clinical Research

The NIAID Transition Program in Clinical Research was initiated in 2006 to provide opportunities for physicians to gain clinical and translational research experience in association with an NIAID intramural laboratory. The program aims to increase the pool of well-trained clinical investigators who are competitive for clinical tenure-track positions. One to three candidates per year will be selected for 3- to 5-year appointments. Applicants must have an M.D. or M.D./Ph.D. degree, be board eligible or board certified in a sub-specialty (or equivalent), and qualify for credentialing by the NIH Clinical Center.

In 2013, there were two new participants in this program; three of the 2012 participants continued in the program in 2013 and one was offered a position in another Institute.

In 2014, there were two new participants in this program; two of the 2013 participants continued in the program in 2014. One of the 2011 participants was offered a tenure track position in NHLBI.

In 2015, there were no new participants. One of the 2010 participants was offered a tenure track position at the University of Mississippi. Another of the 2010 participants was offered a position at the FDA.

In 2016 there was one new participant in the program. There are 5 participants currently in the program.
In 2017, an additional participant was added to the program. One participant was offered a tenure tract position in the VRC. There are 5 participants currently in the system.
In 2018 2 additional participants were added to the program. One participant was chosen to be a Lasker tenure track investigator. One participant has accepted a position at a university and will be leaving in the fall of 2018.
In 2019, 2 additional participants were added to the program. One participant joined NIAMS as staff Clinician. One participant entered a tenure track in Canada
In 2020, 1 additional participant was added to the program. One participant was chosen to be a Lasker tenure track investigator.
In 2021, 2 additional participants were added to the program. One participant was hired as a staff clinician in LPD.
In 2022, 2 additional participants were added to the program. One participant was offered a tenure track position at the University of Pittsburgh.
In 2023, 2 additional participants were added to the program. One participant announced her departure for industry.